Binding of MMP13 to Immune Checkpoint Receptor PD-1H links Bone Disease with Immune Suppression in Multiple Myeloma

Multiple Myeloma (MM) bone disease remains one of the most dreaded complications of this still incurable
cancer. Osteoclast-activating factors produced by MM cells induce osteoclasts, cause excessive bone
resorption, and lytic bone lesions in ~80% of patients with poor healing even after achieving disease remission.
In an effort to screen for potential myeloma-derived factors that activate osteoclasts, we identified matrix
metalloproteinase 13 (MMP-13) to be highly secreted by primary MM cells and elevated in patients with bone
disease. MMP-13 dose-dependently induces extensive bone resorption in vitro and in vivo. In MM bone disease
mouse models, MMP-13 knockdown in MM cells significantly inhibits the development of lytic bone lesions,
confirming that MMP-13 is critical for the development of multiple myeloma bone disease. It is of particular
importance that MMP-13-dependent osteoclast activation occurs independently of its enzymatic activity, thereby
establishing a new paradigm in the regulation of bone resorption. In overview, we have shown that MMP-13
plays a pivotal role in MM-induced bone destruction.
We now have compelling evidence that immune checkpoint protein programmed death-1 homolog (PD-1H), a
transmembrane protein broadly expressed on various hematopoietic cell lineages, serves as a
previously unrecognized signaling receptor for MMP-13. We found that Pd-1h knockout in osteoclast blocks
MMP-13-induced osteoclast activation and bone resorption, suggesting that MMP-13 binding to PD-1H plays a
critical role in MM induced bone disease. Furthermore, we show that MMP-13 has a PD-1H mediated inhibitory
effect on T cell expansion. Mmp-13-/- antigen presenting cells have increased stimulatory capacity on
alloreactive T cells in vitro. In an in vivo model of alloreactivity, donor T cells expand significantly more in Mmp-
13-/- recipients, confirming that host MMP-13 expression mitigates the expansion of T cells.
It is the central hypothesis of this grant that PD-1H is the key receptor for MMP-13 signaling and mediates
its effects on osteoclasts, antigen presenting cells and T cells, resulting in bone resorption and
immunosuppression in MM. We propose the following 4 Aims: 1) Define the role of PD-1H as the MMP-13
receptor in osteoclasts; 2) Characterize the role of the MMP-13/PD-1H axis in skeletal remodeling and MM bone
disease; 3) Investigate the role of the MMP-13/PD-1H axis as an immune checkpoint in MM; and 4) Confirm the
role of MMP-13/PD-1H axis in MM bone disease and immunosuppression in MM patients. Together, our findings
highlight a previously unrecognized and new pathway of osteoclasts activation involving MMP-13/PD-1H axis
that links the bone disease with immunosuppression in MM. We propose that our work will form the basis for novel
treatment strategies in MM bone disease associated with suppressed immune response. Furthermore, this
research will help to better understand the interaction between MM bone disease and the myeloma immune
environment.

Public health relevance
Multiple Myeloma (MM) is an incurable cancer characterized by the development of devastating lytic bone disease and accompanied by compromised immunosurveillance. We found that matrix metallopeptidase-13 (MMP-13) secreted by MM cells induces bone resorption resulting in lytic bone lesions, and discovered that MMP-13 binds to the novel immune checkpoint protein programmed death-1 homologue (PD-1H), which is expressed on osteoclasts, antigen presenting cells and T cells. This grant for the first time investigates the role of MMP-13/PD-1H interaction and their functions in linking bone disease and immunosuppression in MM, hence will form the basis for novel treatment strategies and help better understand the role of MM bone disease in the suppressed myeloma immune environment.